Improving long-term retention of generalized knowledge and detailed memory by shaping neural representations during learning

PROJECT SUMMARY Optimal learning methods often differ based on task goals, whether it be enhancing generalized knowledge that can be flexibly applied to new contexts or remembering specific details of a single event. Research has identified different neural codes that support these two different types of learning: integrated representations stored in anterior hippocampus (aHPC) and medial prefrontal cortex (mPFC) promote knowledge that is generalizable, whereas pattern separated representations stored in posterior hippocampus (pHPC) and lateral prefrontal cortex (lPFC) promote descrimination and specificity. However, there is a general lack of understanding of how integrated and separated neural representations may compete or interact, and how different learning experiences can shape the formation and retention of different neural representations to drive subsequent behaviors. Thus, the overarching goal of this proposal is to identify the mechanisms and training conditions that promote the successful acquisition and retention of different types of knowledge. We propose a neuro-­computational approach to examine category learning, which allows us to simulteneously measure and assess trade-­offs associated with the acquisition and retention of generalized (category-­level) and detailed (exemplar-­level) knowledge as a function of different learning experiences. In Aim 1, we will use model-­based fMRI analyses to characterize how attention biases formation of neural representations in aHPC via interactions with mPFC to improve generalization at the cost of specificity. In Aim 2, we will manipulate stimulus presentation order to determine how different learning experiences can bias individuals to form general (integrated) vs. specific (pattern-­separated) knowledge representations in HPC and PFC using representational similarity analysis (RSA) techniques. In Aim 3, we will use connectivity measures and RSA to identify neural patterns within the HPC-­PFC circuit that predict successful consolidation of general vs. specific information and determine the conditions associated with successful long-­term retention of knowledge. Findings from these proposed studies can help uncover ways to improve training paradigms and target learning interventions to individualize and optimize knowledge retention. This research is particularly relevant to patients with Alzeimer’s disease, epilepsy, and dementia, who experience profound deficits in learning and memory retention.

Public health relevance
PROJECT NARRATIVE The proposed research examines how neural representations are shaped during different learning experiences to promote learning and memory retention through distinct mechamisms. In doing so, this research will provide important insights into targeting learning interventions that can enhance the acquisition and retention of knowledge in various clinical populations. Findings from this research will provide important insights into helping individuals suffering from neurological disorders such as Alzheimer’s disease, epilepsy, and stroke- induced dementias compensate for associated learning and memory deficits by optimzing training conditions that promote the formation of neural representations associated with long- term retention.